Leptospira prevalence, cycling, and infection in the peridomestic environment

Project Summary
Leptospirosis is a common zoonotic disease most prevalent in the tropics (Hawaii, US territories, and worldwide).
Non-specific symptoms cause underreporting and of the 1.03 million reported cases annual worldwide, ~6% die.
Infectious Leptospira bacteria contaminate the environment when shed in urine from mammalian hosts, and
humans can contract leptospirosis directly from infected urine or from contaminated soil and water. While case
interviews have identified risk factors for human infections and potential reservoirs, the few molecular and
microbiological investigations of human cases almost always failed to confirm hypothesized sources, suggesting
that exposure and possible sources have not been adequately defined and environmental cycling across hosts,
space, and time is poorly understood. The complex ecology of this disease involves various host species, survival
in the environment, massive pathogen genetic diversity, and seasonal variation in human cases, all of which are
poorly characterized and poorly understood. Difficulties in culturing Leptospira have restricted the use of modern
molecular tools that, for other pathogens, have been critical for understanding cycling and confirming or refuting
source hypotheses generated using traditional epidemiological approaches. However, we recently developed a
culture-free method for high-resolution genotyping of Leptospira, enabling us to characterize cycling patterns
across hosts, space, and time, and provide high-quality evidence linking infections to specific sources.
For this study, we focus on peridomestic environments (where animals live near human habitations) because
they are likely an important, underestimated, and poorly understood source for human infections in rural areas.
Our field site is in Calderon Parish in Manabí, where leptospirosis cases are most prevalent in Ecuador.
Compared to urban areas where leptospirosis is typically studied, low-income rural areas are fundamentally
different: families typically own a variety of animals and livestock that roam in and around homes creating
exposure potential that is largely absent from urban environments. We will systematically sample peridomestic
environments (humans, other animals, and soil) to characterize variation in prevalence, pathogen load, and
genotype across hosts, time, and space. We will also recruit leptospirosis patients to perform microbiological
and molecular investigations of their peridomestic environment to determine what, if any, peridomestic reservoirs
are likely sources for these human infections.
This study will provide novel insights into the prevalence and cycling of this pathogen in hosts and soil in the
peridomestic environment and each investigation will generate novel and powerful molecular and microbiological
evidence to exclude or confirm the peridomestic environment as the source of each human infection.
Comparisons across these investigations will provide insights into how widespread such sources are in this
region of Ecuador and will form the basis for future investigations to determine the generalizability of these
patterns. Results will fill massive knowledge gaps critical for transmission control and disease prevention.

Public health relevance
Project Narrative Infectious Leptospira cause leptospirosis following contact with mucosa through wounds or ingestion, leading to headaches, fever, jaundice, kidney or liver failure, or death in about 1.03 million people each year. These bacteria are found worldwide and are shed in urine into the environment by mammalian hosts, however almost nothing is known about temporal and spatial pathogen population dynamics and the importance of different mammalian host species in cycling and transmission to humans. This information is essential for controlling and avoiding disease.